Ice-free vitrification and nano warming technology for banking of cardiovascular structures.

ABSTRACT
This proposal focuses on translation of ice-free cryopreservation by vitrification employing a novel approach of
volumetric heating by nanowarming using Fe nanoparticles in an alternating electromagnetic ﬁeld. Vitrification,
sub-zero storage below the glass transition temperature in a “glassy” rather than a crystalline frozen phase, is
a form of cryopreservation that avoids ice formation. Vitriﬁcation can be achieved by quickly cooling the
material to cryogenic storage temperatures, where ice cannot form. Vitriﬁcation can be maintained at the end
of the cryogenic protocol by quickly rewarming the tissue to temperatures above the temperatures where ice
nucleation may occur. The magnitude of the rewarming rates necessary to maintain vitriﬁcation is much higher
than the magnitude of the cooling rates that are required to achieve it in the ﬁrst place. The most common
approach to achieve the required cooling and rewarming rates is by convection based boundary warming in
which the the specimen's surface is exposed to a temperature controlled environment, such as a fluid bath.
Due to the underlying principles of heat transfer, there is a size limit in the case of surface boundary heating
beyond which crystallization cannot be prevented at the center of the specimen. Furthermore, due to the
underlying principles of solid mechanics, there is also a size limit beyond which thermal expansion in the
specimen can lead to structural damage and fractures. Volumetric heating by nanowarming during the
rewarming phase of the cryogenic protocol can alleviate these size limitations. Vitrification is already an
important enabling approach for reproductive medicine with the potential to permit storage and transport of
cells, tissues and organs for a great variety of biomedical uses. Unfortunately, practical application of
vitrification has been limited to smaller systems such as cells and thin tissues due to diffusive and phase
change limitations that preclude use for blood vessels, larger tissues and organs. To circumvent this problem
we demonstrated that nanowarming effectively rewarms blood vessels in our preliminary research. Our
experiments demonstrated that this innovative rewarming technique rewarmed vitrified femoral and carotid
arteries in volumes ranging from 1 to 50mL with retention of cell viability and physiologic function.
However, warming of thick arteries was suboptimal. We propose using large animal blood vessel, models
for further optimization and evaluation of nanowarmed vessels using a combination of in vitro and in vivo
studies. In Phase 1 in a single specific aim we will optimize ice-free vitrification of thick walled arteries,
aorta and pulmonary, with a go/no go objective of achieving > 90% viability for progression to Phase 2. In
Phase 2 specific aims, we propose using porcine vascular models in a combination of ex vivo and in vivo
studies. The magnetic nanoparticles will be distributed around and within the internal spaces of vessels.
The large vessel lumen space makes them a good choice for optimization of vitrification and
nanowarming. In Aim 1 we will evaluate cryopreserved arteries after real time shipping, comparing methods
and validating the transport conditions that are finally approved based upon absence of tissue cracking. In Aim
2 we will characterize the post-ice-free cryopreservation state of arteries preserved for at least 2 years. In
addition, during this aim we will characterize the chemistry and biomaterial properties of ice-free
cryopreserved blood vessels. Effective vitrification will be evaluated using cryomacroscopy to detect ice
formation and cryoprotectant residuals by Raman spectroscopy. In Aim 3 we will perform short-term
transplant studies (28 days) in two porcine vascular models (femoral and pulmonary artery into the carotid
and pulmonary, respectively) in order to validate our technology for a future Phase IIb SBIR proposal using
clinically relevant preclinical non-human primate models and human tissues.

Public health relevance
NARRATIVE There are huge markets for research, diagnostic and clinical applications of naturally occurring and engineered cells, tissues and organs. Strategic assessment of the field has identified the need for better preservation methods because freezing methods of cryopreservation have been shown to damage tissues and organs due to ice formation. This proposal focuses on nanowarming technology development for cryopreservation by vitrification of large volume blood vessels samples. Nanowarming is required for viable, functional preservation of blood vessels. There are significant clinical needs for vascular grafts for dialysis as well as patients requiring peripheral and coronary bypass grafts. Advances in the preservation of tissues are also needed for trauma care, particularly to incorporate regenerative medicine products into strategic national stockpiles. This proposal combines the use of novel cryoprotectant formulations with magnetic nanoparticles and radiofrequency- induced warming to warm optimally vitrified, banked, living, biological materials. These technologies could eventually impact hundreds of thousands of patients in North America annually if applied to tissues, tissue engineered cellular constructs and one day organs.